Retroelement-mediated cis-regulation of embryonic hematopoiesis

Summary
The goal of this proposal is to test the hypothesis that the transcriptional program mediating the
process by which endothelial cells in the embryo differentiate into hematopoietic stem and
progenitor cells (HSPCs) is coordinately regulated by cis-acting regulatory sequences derived
from retroelements. Retroelements are repetitive DNA sequences comprising approximately 50%
of mouse and human genomes. The long terminal repeats (LTRs) of the retrotransposon family
of retroelements function as enhancers, promoters, and polyadenylation signals for endogenous
gene expression and are highly enriched for transcription factor binding sites (TFBS). We have
identified families and specific subfamilies of retrotransposons that are more highly expressed in
the small population of endothelial cells in the embryo that differentiate into HSPCs (hemogenic
endothelial cells) than in non-hemogenic endothelial cells, and in particular give rise to progenitors
with potent lymphoid potential. Some of these subfamilies of retrotransposons contain RUNX1
motifs in their LTRs, and we hypothesize that RUNX1 regulates HSPC differentiation from
hemogenic endothelial cells through these LTRs. We will use long read sequencing technology
and bioinformatics approaches adapted for the purpose of analyzing retroelements to map
transcriptionally active retroelements based on their expression and chromatin configuration to
specific genomic coordinates and determine if they activate genes involved in HSPC formation
from hemogenic endothelial cells. We will also determine if the RUNX1 transcription factor
regulates the activity of a subset of these LTRs.

Public health relevance
Project Narrative All blood cells differentiate from a small population of endothelial cells in the embryo. The goal of this research is to understand the role of retroelements, which are DNA sequences making up about half of our genome and for many years considered to be “junk DNA”, in controlling the formation of blood cells in the embryo.